NIH StrokeNet National Clinical Coordinating Center

Project Summary
Stroke is the second leading cause of death worldwide with an even greater burden of major disability. It
occurs at all ages with the greatest incidence in the elderly. The number of strokes is expected to rise in the US
and worldwide as the population ages. In 2013, NINDS established NIH StrokeNet to harness the leadership
and experience of the stroke research field to efficiently create and complete high-quality, multi-site trials and
related biomarker validation and ancillary studies spanning prevention, treatment, and recovery. Since
inception, the National Clinical Coordinating Center (NCC) at the University of Cincinnati has provided overall
leadership and has coordinated activities within NIH StrokeNet. Our central objective is to engage the broader
stroke community to successfully and efficiently design trials that are scientifically important, innovative, and
feasible; to start trials expeditiously after being funded by NINDS; to successfully recruit and retain
representative participants of the US population, and to maintain a pipeline of new clinical trialists by guiding
the training, education, and career development of StrokeNet’s fellows and clinical research professionals. In
addition to providing overall leadership and coordination for 24-27 regional coordinating centers affiliated with
500+ potential study sites, the NCC includes the StrokeNet research pharmacy and imaging activities.
Our NCC team consists of two MPIs with over 50 years of collective experience designing, implementing, and
completing multi-site clinical trials; over 30 NCC staff with in-depth expertise in coordinating, contracting,
regulatory, pharmacy and imaging activities; a high level of support from University of Cincinnati; over 20 NCC
co-investigators across the US with established expertise in the broad range of cerebrovascular disease and
trial methodologies; and numerous international collaborators.

Public health relevance
PROJECT NARRATIVE Stroke is the second leading cause of death and a leading cause of major disability globally, and is becoming more frequent with the aging population. NIH StrokeNet is a network of clinical sites and experts across the country working together to develop and complete multi-site clinical trials, the final step in proving that new potential treatments will work, and to train the next generation of clinical researchers. The National Coordinating Center leads and manages this network to test new ways to treat, prevent, and aid in recovery and rehabilitation from stroke.